Elucidating the role of dynein-cargo adaptor proteins in Human papillomavirus infection

Abstract
Human papillomavirus (HPV) is the etiologic agent of cervical cancer, as well as anogenital and oropharyngeal
cancers. It is also the most common sexually transmitted infection. Despite the availability of prophylactic
vaccines, there are no effective antivirals against active HPV infection. Illuminating the cellular basis of HPV
infection is therefore crucial to therapeutic development. Upon receptor-mediated endocytosis, HPV is
trafficked to the endosome, the Golgi, and then the nucleus to cause infection. How HPV navigates through
this endomembranous network of the host cell remains mysterious. Although recent studies have suggested a
role of the host motor dynein in HPV entry, the molecular mechanism by which dynein promotes HPV infection
remains unclear. Our preliminary data identified two dynein “cargo adaptors” – the endosome-localized FIP3
and the Golgi-localized BICD2 - as critical host factors during HPV infection. These results suggest that HPV
hijacks distinct dynein-cargo adaptor complexes at different entry steps to successfully reach the nucleus.
Based on these findings, we hypothesize that the dynein-FIP3 adaptor complex is exploited to transport HPV
from the endosome to the Golgi (Aim 1), while the dynein-BICD2 adaptor complex traffics the virus from the
Golgi to the nucleus (Aim 2). We will use biochemical, cell-based, and genetic approaches, under loss-of-
function conditions, to elucidate the mechanism by which the dynein-adaptor complex drives viral transport.
We anticipate that clarifying the role of host components in HPV entry will provide novel strategies to combat
HPV-induced diseases.

Public health relevance
Project Narrative Human papillomavirus (HPV) is the most common sexually transmitted infection and is the primary cause of cervical, oropharyngeal, and anogenital cancers. Despite HPV’s heavy public health burden, there remains a limited understanding of the viral entry pathway. This proposal seeks to clarify the role of the dynein cargo adaptors FIP3 and BICD2 in dynein-mediated transport of HPV, which holds the potential to identify new therapeutic targets to combat pre-existing HPV infections.